CARDIOVASCULAR PROCEDURE UTILIZATION IN A COHORT OF ESRD PATIENTS

This CDMAS project is examining usage of cardiac catheterization, TPCA, and CABG before incident dialysis and post incident dialysis and examine if medicare insurance narrows the racial differences in procedure use.